Ano4 and Metabolic Health

PROJECT SUMMARY
Obesity is a major risk factor for many chronic medical conditions, including diabetes, cardiovascular disease,
depression, and cancer. Elucidating the neural mechanisms that regulate feeding behavior and body weight
control is critically needed towards the development of effective strategies to combat obesity and its co-
morbidities. We discovered that anoctamin 4 (Ano4, an ion channel) is abundantly expressed in the area
postrema (AP) in the hindbrain. Activation of these APAno4 neurons increase food intake and blood glucose in
mice. Importantly, a large-scale human genetic study established the association of the ANO4 gene mutation
with human obesity, but the causality of this association has not been tested. The first objective is to determine
physiological relevance of APAno4 neurons in energy/glucose balance. We will use both gain- and loss-of-function
models to establish the function of the APAno4 neurons on feeding and valence behavior, as well as long-term
regulation of body weight and glucose homeostasis. The second objective is to use a Cas9-mediated DNA editing
to delete Ano4 only in AP neurons, and to determine physiological functions of the Ano4 channel on the
excitability of AP neurons and on the whole-body energy/glucose balance. The third objective is to use a
humanized Ano4 knock-in mouse model (mimicking the obesity-associated human ANO4 mutation) to determine
whether this mutation causes obesity in mice and alters Ano4 channel functions. Completion of the proposed
research will identify a novel target that regulates body weight balance in mice and humans, and provide the
necessary framework to develop therapeutic strategies towards treating obesity.

Public health relevance
PROJECT NARRATIVE We discovered that brainstem neurons expressing anoctamin 4 (Ano4, an ion channel) regulate food intake and blood glucose in mice. A large-scale human genetic study established the association of the ANO4 gene mutation with human obesity, but the causality of this association has not been tested. Here we propose to use genetic mouse models to examine the effects of the Ano4 mutation and Ano4-expressing neurons on body weight and glucose homeostasis, which will provide the necessary framework to develop therapeutic strategies towards treating obesity and metabolic dysregulations.